Theoretical and Experimental Studies of the Population and Evolutionary Dynamics of Bacteria and Bacteriophage.

ABSTRACT The viruses of bacteria and archaea, phage, are touted to be the most
abundant organisms on Earth, and a great deal is known about their molecular biology,
structure, and mechanisms of replication. Nevertheless there remain fundamental
unanswered or incompletely answered questions about the population biology,
ecological role, and evolution of these viruses. In this investigation we will address and
provide answers to three of these fundamental questions: 1- What are the ecological,
genetic and evolutionary conditions for lytic (virulent) phage to be maintained in and
regulate the densities of bacterial populations? 2- Under what conditions will selection
favor a temperate rather than a purely lytic mode of phage replication and
transmission? 3- Under what conditions will selection by lytic and temperate phage
favor the evolution and maintenance of CRISPR-Cas mediated adaptive immunity, rather
than envelope or other constitutive resistance mechanisms? To address these
questions, we will use mathematical and computer simulation models, the properties of
which will be analyzed numerically with parameters estimated in the experimental
systems that will be employed for population dynamic and evolutionary experiments.
We will test the predictions (hypotheses) generated from our analysis of these models
in populations of bacteria and phage maintained in liquid, surface, and semisolid
culture. Based on the results of these experiments, we will modify our models to make
them more realistic. The experiments will be done with Escherichia coli, Pseudomonas
aeruginosa, Pseudomonas syringae, and Staphylococcus aureus and their lytic and/or
temperate phage. In addition to their importance to academic ecology, population and
evolutionary biology, the results of this basic science study may well have practical
utility. This investigation will provide an empirically supported theory that could be used
to facilitate the design and evaluation of programs to use phage for the treatment of
bacterial infections in humans and domestic animals, and to control outbreaks of
pathogenic bacteria in crops.

Public health relevance
NARRATIVE Although the viruses of bacteria and archaea (phage) are touted to be the most abundant organisms on Earth and research with bacteriophage has played and continues to play a central role in the development of molecular biology and biotechnology, there remain fundamental unanswered questions about the evolution of these viruses and their contribution to the ecology and evolution of their hosts. The proposed jointly theoretical and experimental study of the population biology and evolution of bacteriophage will address and answer three classes of questions: 1- Existence conditions; under what conditions will phage be maintained and regulate the densities of these host populations? 2- Horizontal versus vertical transmission: under what conditions will natural selection favor the evolution and maintenance of a lysogenic rather than a purely lytic mode of phage replication? 3- The evolution and maintenance of adaptive immunity: under what conditions will selection mediated by virulent and temperate phage lead to the evolution of and maintenance of CRISPR-Cas - mediated adaptive immunity?